Hematopoiesis Training Grant

ABSTRACT
The Hematopoiesis Training Grant at the University of Pennsylvania was founded in 1999 with the primary goal
to prepare graduate students and postdoctoral fellows for careers as successful investigators working in areas
related to hematopoiesis and blood disorders. The Program has trained 30 post-doctoral and 18 pre-doctoral
scientists, including 3 post-doctoral and 4 pre-doctoral trainees currently in training. It is a multi-disciplinary,
cross-departmental training program that capitalizes on the extensive resources of the Penn School of Medicine
(PSOM), the Children’s Hospital of Philadelphia (CHOP), and School of Veterinary Medicine. The Program draws
pre-doctoral candidates from the large and highly regarded PhD and MD-PhD programs at the PSOM and post-
doctoral applicants from the competitive hematology and pathology fellowship programs at PSOM and CHOP,
and from leading laboratories in the basic science departments at Penn. Research mentorship is provided by 30
scientifically diverse trainers of all academic ranks with research interests that encompass virtually all areas of
hematopoiesis as well as young faculty who bring in cutting-edge technology to hematology research. The
academic elements of the Program include an integrated curriculum of coursework, seminars, laboratory work,
skills training, formal and informal mentoring and career counseling, presentation, and manuscript and grant
writing, which are effectively combined to train new investigators in the fundamentals of hematopoiesis. Trainees
are evaluated on the basis of written and oral presentations, Individualized Development Plans, and status
conferences with the PI/PD and both research and Program mentors. The success of this comprehensive
approach is indicated by the 100% graduation rate with first-author papers, the large numbers of predoctoral
appointees continuing in postdoctoral research, the number who have been awarded funding following Program
graduation, the number of trainee publications directly related to their T32 supported research (postdoctoral
alumni averaged 4.3 peer-reviewed papers and predoctoral alumni 3.6 papers), and the number of postdoctoral
appointees who have progressed to leadership positions in academia (56%) and industry (32%). The
Hematopoiesis Program underwent a change in leadership in December 2017. The new PI/PD is well supported
by the experienced Oversight Committees, including an Internal Advisory Board (IAB) and a new External
Advisory Board (EAB). A comprehensive review by the PI, IAB and EAB in the inaugural T32 retreat resulted in
the recommendation to increase the interactions among the trainees/mentors by establishing annual retreat and
quarterly research seminars and instituting mentor training for all ranks. The review also identified a large pool
of highly qualified pre-doctoral MD-PhD students at Penn with career interests in hematopoiesis, as well as a
continuous influx of faculty in hematopoiesis-focused research to Penn/CHOP. Consequently, this application
requests one additional position that is dedicated to these combined-degree students and another new postdoc
position to encourage and support their career progression in hematopoiesis research.

Public health relevance
PROJECT NARRATIVE The Hematopoiesis Training Grant provides training and mentoring to pre- and postdoctoral trainees in hematopoiesis and hematopoietic stem cell biology. Advances in hematopoietic biology and its importance to clinical practice have created a demand for training in this field and a corresponding shortage of qualified training opportunities. The current Program addresses this shortfall by identifying outstanding pre- and postdoctoral scientists interested in hematopoiesis and providing the training that will allow them to become leaders in biomedical research, teaching, and biotechnology.